Mechanisms of Beta-blocker Induced Improvements in Asthma

DESCRIPTION (provided by applicant): Asthma is characterized by reversible airway obstruction, airway hyperresponsiveness (AHR) and airway inflammation. The medications used for control and acute relief of asthma vary in their effectiveness and may produce serious side effects. Thus, there is a need to develop new and improved medications for asthma. Our research has shown that, unexpectedly, activation of the β2AR is necessary for the development of the asthma phenotype produced by antigen challenge or by direct intra-tracheal administration of IL-13. We have also shown that chronic treatment of mouse models of asthma with β2AR-inverse agonists produced broad anti- inflammatory effects in the airways, including dramatic changes in airway epithelium mucus production and morphology. These data suggest that β2ARs located on the airway epithelium may be a key target for the effect of β2AR inverse agonists. Our long-range goal is to determine the mechanism of the proasthamtic effect of β2AR signaling. To do this we need to understand the signaling pathways and their sites of action. In this project, we will: Aim 1. Test the hypothesis that an important target of β2AR-inverse agonists is the airway epithelium, and determine what components of the asthma phenotype are due to lung parenchymal cells versus hematopoietic cells by using genetically altered mice and bone marrow transplantation experiments. Aim 2. Determine the role of β2AR-β-arrestin-2-MAPK signaling, in mediating the pro-asthmatic effects of the β2AR using genetically altered mice and human bronchial airway epithelial cells, and Aim 3. Using pharmacological and genetic 'sympathectomy', as well as bone marrow transplant experiments, determine the cellular source of the epinephrine activating the β2AR allowing its various pro-asthmatic effects, and because weeks of treatment required for the anti-asthmatic effect of β2AR-inverse agonists, we will perform microarray analysis for gene expression changes as a lead for possible mechanisms of action. This research could lead to safer and more efficacious drugs for the treatment of asthma, and alter our understanding of asthma at a paradigm-shifting level.

Public health relevance
The relevance of this project is that it could lead to new safer and more effective drugs for the treatment of asthma. Furthermore, the results could alter our understanding of the beta-2-adrenergic receptor in asthma at a paradigm-shifting level.